Administrative Core

Project Summary: Administrative Core
Co-led by Nadia Islam, Chau Trinh-Shevrin, and Janet Brown-Friday, the Administrative Core (AC) will oversee
and support the administrative and fiscal management and coordination of the National CEDER activities across
Cores and partners. Using participatory processes, we will work closely with the leads of the Stakeholder
Engagement Studio (SES) and Research Consultation Services (RCS) Cores (each co-led by academic and
community partners), and our robust network of academic institutions and other multi-sector stakeholders,
including community, healthcare, municipal, and professional society partners. Together, we will support and
sustain Center services focused on strengthening the engagement of communities and individuals from diverse
backgrounds and multiple sectors in Type 2 diabetes research across the United States. The AC will be
organized by two key structures: 1) a Steering Committee comprising leads from the AC, SEC and RCS cores,
and NIDDK officers; and 2) a Partnership Hub that will leverage our extensive academic and community partner
network, including academic and community co-investigators, to serve as expert consultants in community
engagement and to identify users of Center services. The Partnership Hub includes specific leadership from 18
academic sites and 10 regional and national organizations representing diverse racial and ethnic communities,
geographic areas (including rural and urban areas), and communities experiencing historical marginalization
across the U.S. (including immigrant, sexual and gender minority, and low-income communities) whose expertise
will shape CEDER strategic planning and service delivery. The AC (with input from the Steering Committee and
Partnership Hub) will develop a process to identify and compensate additional consultants through the
Partnership and Outreach Fund across the 5-year cycle, ensuring National CEDER maintains a robust network
of expertise in community engagement in T2D research that is responsive to service requests. AC aims are to :
1. support a centralized infrastructure to coordinate and monitor across cores, Center partners, and diverse
stakeholder groups; 2. provide administrative infrastructure to support the development, implementation,
monitoring, and maintenance of the Center's service delivery model; 3. establish, implement, monitor, and
maintain robust internal and external communication and dissemination plans for the Center and across
Partnership Hubs; and 4. evaluate the Center's progress in achieving short-and long-term goals. The AC will
support a robust and sustainable infrastructure to advance community-engaged diabetes equity research among
diverse racial and ethnic and geographic communities across the U.S.